Impact of Airway Inflammation on Mitochondria

The impact of acute airway inflammation is mediated by pro-inflammatory cytokines (e.g., TNFα),
and underlies a number of respiratory diseases. A fundamental question is why are some
individuals more susceptible than others to the negative impact of airway inflammation. We will
explore a novel homeostatic mechanism, which protects airway smooth muscle (hASM) cells from
the negative impact of inflammation-induced reactive oxygen species (ROS) formation and
protein unfolding (endoplasmic reticulum (ER) stress). We believe that a failure in this homeostatic
mechanism leads to increased ROS formation thereby exacerbating oxidative and ER stress.
Overall Hypothesis: TNFα-induced ROS formation and protein unfolding activates the
pIRE1α/XBP1s ER stress pathway in hASM, which initiates a homeostatic response directed
towards increasing mitochondrial biogenesis and mitochondrial volume density to reduce O2
consumption and ROS formation by individual mitochondrion, while still meeting the increase in
ATP demand – sharing the energetic load across mitochondria. Furthermore, reduced Mfn2
disrupts mitochondrial tethering to the ER, thereby decreasing mitochondrial Ca2+ influx and
maximum respiratory capacity of mitochondria.
Aim 1: TNFα-induced activation of pIRE1α/XBP1s ER stress pathway increases mitochondrial
volume density and reduces O2 consumption and ROS formation per mitochondrion.
In hASM cells, the downstream impact of TNFα-induced activation of the pIRE1α/XBP1s ER
stress pathway will be explored using transfection of a non-phosphorylatable IRE1α mutant
plasmid (DP-IRE1α) or an unspliceable XBP1 (uXBP1) mRNA. In addition, we will examine the
effects of siRNA knockdown of PGC1α and Mfn2 overexpression on TNFα-induced changes in
mitochondrial biogenesis, mitochondrial volume density, O2 consumption and ROS formation.
Aim 2: TNFα-induced reduction in Mfn2 disrupts mitochondrial tethering to ER, decreases
mitochondrial Ca2+ influx and reduces maximum respiratory capacity of mitochondria.
In hASM cells, we will examine the impact of DP-IRE1α or uXBP1 mRNA transfection and
siRNA Mfn2 knockdown on TNFα-induced disruption of mitochondrial/ ER tethering, decreased
mitochondrial Ca2+ influx and reduced maximum respiratory capacity of mitochondria.
Aim 3: The impact of TNFα on activation of the pIRE1α/XBP1s ER stress pathway and
downstream effects are mitigated by ROS scavenging and chemical chaperone treatment.
In hASM cells, the mitigating effects of ROS scavenging and chemical chaperone treatment
on TNFα-induced activation of the pIRE1α/XBP1s ER stress pathway will be examined.

Public health relevance
PROJECT NARRATIVE With the COVD-19 pandemic, we are keenly aware of the impact of airway inflammation, which is mediated by pro-inflammatory cytokines such as TNFα. Inflammation is a key aspect of airways diseases such as asthma that affect more than 20 million people in the USA and 300 million people worldwide. The proposed studies will focus on human airway smooth muscle (hASM) and the effects of pro-inflammatory cytokines in inducing stress on the endoplasmic reticulum (ER). In hASM cells, we will explore the involvement of TNFα in selectively activating an ER stress signaling cascade, and how this affects the downstream expression of proteins that regulate mitochondrial structure and function.